Chemistry Core

Abstract
The center uses novel strategies to determine the mechanism(s) of action for the anti-
depressant actions of neurosteroids. A panel of neurosteroid analogues with a range of
previously determined mechanisms of action will be synthesized in the Chemistry Core for use
in all Projects in the center. These include analogues with actions at NMDA receptors, GABAA
receptors, Ca2+- channels, and intracellular targets. New tethered compounds will be
synthesized to restrict actions to plasma-membrane channels. Existing and proposed
photoaffinity labeling neurosteroids will be prepared in the core and used in Project 1 to identify
novel sites. The core is a hub for evaluation of the impact of neurosteroids with varied cellular
actions.

Public health relevance
Narrative The neurosteroid brexanolone has recently been approved for the treatment of postpartum depression and other neurosteroids are being evaluated for the treatment of major depressive disorder. The mechanism of action whereby neurosteroids ameliorate depression is currently unknown. This core will provide a panel of neurosteroid analogues with different mechanisms of action that will be used in Projects 1 – 3 to determine physiologic molecular targets and pathways that underlie the antidepressant actions of neurosteroids.